The Physiology of the Weight Reduced State Data Coordinating Center

Supplemental funding is requested for the Data Coordinating Center (DCC) for the Physiology Of the
Weight Reduced State (POWERS) consortium. Though the Request for Application indicated that there
would be support for “up to two Clinical Centers”, one of the successful applicants now includes 4
institutions. With the DCC budgeting the single IRB (sIRB) costs for two Clinical Centers, additional
funding is needed due to additional costs for IRB costs for the 5 institutions comprising the two Clinical
Centers. Additionally, the funding for the study website did not include costs related to using the
website as a recruitment tool or for data collection, which is now being done. Finally, the more
extensive data collection being proposed once the protocol began to be developed, including data
streams from several devices, was not including in our original application.

Public health relevance
The POWERS consortium developed a protocol that includes substantially more data collection, from more data streams, than was envisioned in our proposal. The website has more functionality. With one of the Clinical Centers including multiple institutions, the costs for the single IRB are higher than anticipated.